Community Engagement Core

PROJECT SUMMARY/ABSTRACT – COMMUNITY ENGAGEMENT CORE
Decades of industrial and agricultural processes have left North Carolina with historic and
emerging environmental health issues that are of interest to researchers and communities.
Since 2015, the Center for Human Health and the Environment (CHHE) has brought together
investigators with multidisciplinary expertise in environmental health sciences (EHS) to
address these issues and create meaningful impacts for North Carolinians. The Community
Engagement Core (CEC) facilitates multi-directional communication, drawing on the expertise
of educators, and extension and community organizations to translate CHHE research into
essential resources needed to understand and address local EHS concerns. The CEC’s vision for
the next five years is to use an asset-based approach to community engagement with a focus
on environmental health literacy (EHL), mobilizing existing knowledge and capacity within
CHHE’s engagement audiences to address environmental health concerns. This vision aligns
with CHHE’s mission and NC State’s land-grant commitment to innovative problem solving for
the people of North Carolina. To do this, the CEC proposes four specific aims closely integrated
with the larger Center infrastructure. Aim 1 will communicate Center research to CHHE
engagement audiences and share their fundamental EHS concerns with the Center. Successful
knowledge flow will involve the Stakeholder Advisory Board and Administrative Core, the
deployment and analysis of surveys, and a variety of resources developed with the
Translational Research Support Core. Aim 2 will create a shared understanding of assets and
build capacity among engagement audiences and Center members to address important EHS
issues collaboratively. The goal is to build each group’s skills in complementary areas–the
audiences’ ability to participate in EHS and Center members’ ability to engage on local EHS
issues–while establishing the importance of leveraging the expertise of others. Activities in
this aim will enhance the way both groups address EHS issues. Aim 3 will promote
collaborative partnerships between engagement audiences and Center members to address
fundamental EHS questions by identifying opportunities for community-driven environmental
sample analysis with CHHE members, maintaining a database of Community Grant and Pilot
Project Program applicants, coordinating events for Center members and CEC audiences, and
providing mentorship opportunities with educators. Finally, Aim 4 will evaluate the impact of
CEC programming. Using evaluative feedback, we will assess dimensions of EHL and
communication of EHS issues among our engagement audiences. Evaluation will ensure CEC
activities reflect the changing needs of the CEC’s audiences, provide evaluation materials for
broader use, and produce new knowledge that advances community engagement practice.
Through an asset-based approach, the CEC aims to build environmental health knowledge,
create shared capacity, and cultivate collaborative partnerships for EHL and improved public
health.